Control of retinal cell fate specification by the miR9-2 disease gene locus

PROJECT SUMMARY
The development of a functional central nervous system is dependent upon the proper specification of distinct
cell fates by multipotent progenitor cells. While the role of protein-coding genes in this process is well studied,
there is a pressing need to understand how non-coding elements, such as microRNAs (miRNAs) and
enhancers, contribute to cell fate decisions as a growing number of studies implicate non-coding genomic
elements in disease. The long term goal of this project is to elucidate how the microRNA, miR9-2 regulates the
timing of cell fate specification during retinal development. miR9-2, along with its distal enhancer, has been
linked to retinal disease and associated phenotypes, and disruption of miR9-2, through deletion of its
enhancer, can delay the emergence of late-born cell classes. Therefore, the hypothesis of this proposal is that
miR9-2, in coordination with its enhancer, regulates specific target transcripts in progenitor cells to control the
timing of neurogenesis during retinal development. Here, using in vivo mouse models, single-cell sequencing,
and machine-learning directed enhancer bashing approaches, this proposal will dissect the functional role of
miR9-2 and its enhancer to understand the regulatory role they play in proper specification of retinal cell
classes. The proposed research is significant, because it will provide a comprehensive understanding of the
enhancer-miR9-2 regulatory unit and the gene networks, cell classes, and retinal structures under its control.
This will further provide an opportunity to model the mechanisms of action by which non-coding elements
influence the development and diseases of the central nervous system and may lead to gene targets and
pathways with therapeutic potential.

Public health relevance
PROJECT NARRATIVE The nervous system is composed of cell classes of varied form, function, and genetic profile, yet often these cells originate from the same population of multipotent progenitors. Here, I propose to elucidate the genetic networks regulated by the microRNA, miR9-2 and its distal enhancer, using an in vivo miR9-2 knockout mouse model which has been found to have retinal structure perturbations. This project will fill a gap in our knowledge regarding the specific role of miR9-2 in cell types of the developing retina, its function as a genetic regulator, and its potential contribution to disease.